Implementation strategies for caregiver and teacher use of behavioral interventions with ADHD: A pilot study

PROJECT SUMMARY
Well-established psychosocial interventions for children with or at-risk for ADHD include behavioral parent
training at home and behavioral classroom management interventions at school, both of which show strong
meta-analytic evidence of effectiveness. These approaches involve adults using antecedent- and
consequence-based interventions to create contexts in which children are more likely to succeed. Moreover,
the home-school relationship is critical for children's success in school and home, and interventions aiming to
promote family-school collaboration are effective at improving outcomes of children with ADHD. However,
caregivers need implementation supports to implement evidence-based antecedent- and consequence-based
interventions with fidelity, and caregivers often have difficulty accessing behavior therapy in community
settings. Preliminary data from our ongoing work developing and pilot testing implementation strategies for
teachers in partnership with the School District of Philadelphia suggests an additional need for caregiver-facing
implementation strategies to support behavioral intervention and home-school communication. Schools are a
promising setting in which to provide early intervention for mental health challenges and to increase access to
mental health care. Furthermore, stronger integration between home- and school- based interventions has the
potential to meaningfully improve child outcomes. Therefore, we propose to develop implementation strategies
for caregivers (Supporting School Success [SSS-C]), disseminated through schools and designed to address
the specific needs of caregivers, to support caregivers of children with or at-risk for ADHD in implementing
evidence-based behavioral interventions and home-school communication approaches. These caregiver-facing
implementation strategies will be designed in coordination with the teacher-facing implementation strategies
(SSS-T). To prepare for a large-scale R01 Hybrid Trial, we will address two specific aims: (1) Develop and
field-test caregiver-facing implementation strategies (SSS-C); (2) Pilot test SSS-C, together with the existing
SSS-T implementation strategies to prepare for a large-scale Hybrid Trial. During Aim 1, we will use an
iterative, community-partnered approach to develop SSS-C, refine it in partnership with a Stakeholder Advisory
Board based on feedback from try-outs with caregivers, and make final adjustments based on a field pre-test.
During Aim 2, we will conduct a small-scale randomized pilot trial with 40 children and their caregivers and
teachers, and will collect implementation outcomes (i.e., acceptability, appropriateness, feasibility, caregiver
and teacher fidelity) and child outcomes (i.e., ADHD symptoms, functional impairment, academics, student-
teacher relationship). We will also mixed methods to examine the hypothesized mechanisms, based on the
Theory of Planned Behavior, of the caregiver- and teacher-facing implementation strategies.

Public health relevance
PROJECT NARRATIVE Behavioral interventions at home and school, as well as the communication between home and school, are critical in shaping the mental health outcomes of children with or at-risk for Attention Deficit/Hyperactivity Disorder (ADHD), a prevalent and impairing mental health condition, but caregivers and teachers need implementation supports to use behavioral interventions with fidelity. Using a community participatory approach, we will develop implementation strategies for caregivers to support their use of behavioral interventions as early intervention for children with or at-risk for ADHD, and pilot test them alongside existing teacher-facing Coordinated caregiver-facing and teacher-facing implementation strategies, disseminated through schools, have the potential to promote healthy outcomes for children with ADHD on a large scale.